IGF::OT::IGF : SYNTHESIS AND DISTRIBUTION OF OPIOID AND RELATED PEPTIDES. PERIOD OF PERFORMANCE: 02/15/2017-02/14/2022. N01DA-17-7795.

*Synthesis and purification of opiod and related pepetides (Radiolabeled and/or unlabeled) at a purity of 99% minimum. *Maintainance ofteh NIDA Drug Inventory (DISCS) and shippign and distribution of peptides in inventory based on NIDA requests. *Bi-annual literature review and summary report on teh pertinent opioid peptides related publications. *Manufacturing proces development for new peptides to include in NIDA Drug Inventory Supply.